SOMATROPIN THERAPY IN HYPOPITUITARY CHILDREN

Somatropin (natural sequence HGH) is used in children with growth hormone deficiency to evaluate their response in promoting linear growth and determining the safety of Somatropin.